Minimizing myocardial damage and loss of cardiac function post myocardial infarction using Targeted PKC inhibitors 002 and 004.

Abstract.
This Phase II SBIR proposal focuses on the advanced development and validation of YT-002 and YT-004,
innovative compounds targeting Protein Kinase C epsilon (PKCε) and Protein Kinase C beta II (PKCβII),
respectively, to preserve myocardial tissue and function following infarction. The research is meticulously
planned to not only refine the pharmacokinetic/pharmacodynamic (PK/PD) profiles of these agents but also to
conduct in-depth long-term safety and efficacy studies in porcine models, paving the way for Investigational New
Drug (IND) applications. Specific aims include: 1) Optimization of drug formulations to enhance stability, ensuring
effective delivery and action within the myocardium. 2) Detailed pharmacokinetic studies to thoroughly
investigate absorption, distribution, metabolism, and excretion (ADME) properties, providing a solid foundation
for dosing regimens. 3) Comprehensive pharmacodynamic assessments to evaluate the long-term impact of YT-
002 and YT-004 on myocardial infarct size and cardiac function, emphasizing sustained cardiac protection over
extended periods. The project leverages advanced modeling techniques to establish a robust correlation
between drug dosage/concentration and therapeutic outcomes, enabling the prediction and optimization of
effective therapeutic windows. This includes employing non-linear mixed-effects modeling for PK data and
analysis of variance (ANOVA) for PD endpoints, ensuring precise quantification of the drugs' cardioprotective
effects. By systematically addressing these objectives, the proposal aims to confirm the long-term benefits of
YT-002 and YT-004 in reducing myocardial damage, and the incidence of heart failure substantiating their
potential as groundbreaking treatments for myocardial I/R injury. Success in these endeavors will not only
facilitate the transition of these compounds to clinical trials but also potentially set new benchmarks in the
treatment of cardiovascular diseases, significantly improving patient outcomes and quality of life post-myocardial
infarction. Overall, this project represents a comprehensive effort to bring novel, targeted therapies from
preclinical development into clinical readiness, offering promising new avenues for the effective management of
myocardial I/R injury. Through rigorous research and innovative approaches, we aim to advance the
understanding and treatment of this critical cardiovascular condition, ultimately contributing to enhanced health,
prolonged life, and a reduction in the morbidity and mortality associated with myocardial infarction.

Public health relevance
Project Narrative: The development of YT-002 and YT-004 for protecting post myocardial infarction injury promises a significant leap forward in cardiovascular medicine. Targeting specific molecular pathways involved in cardiac damage, these compounds offer a novel approach to reducing heart injury and improving long-term patient outcomes post-myocardial infarction. Successful advancement through Phase II trials and into clinical studies could dramatically change the treatment landscape for heart attack survivors, reducing the risk of heart failure and other long-term complications. This project represents a critical step towards fulfilling the urgent need for more effective treatments in cardiovascular care, with the potential to significantly impact public health by enhancing patient recovery and quality of life after a heart attack.